Identification and characterization of the class I and class II MHC molecules of the Syrian hamster to enable advanced studies of T cell immunity

PROJECT SUMMARY
The Syrian hamster (Mesocricetus auratus) is a valuable model for the study of many RNA viruses,
including SARS-CoV-2, as well as numerous other diseases relevant to human health. T cells are an important
component of SARS-CoV-2-specific adaptive immunity, and they represent a key potential correlate of immunity
or immunopathology in viral diseases in general. Remarkably, T cell immunity cannot be readily evaluated in
Syrian hamsters at present, because their MHC molecules have not yet been identified. The lack of knowledge
regarding the identity of the MHC molecules of Syrian hamsters has limited the ability of the model to support
advanced investigations of cellular immunity in the response to human pathogens and vaccines. Filling this
knowledge gap will be necessary to fully realize the promise of the Syrian hamster as an animal model for human
diseases and is the primary objective of our proposed work. As a result of our analysis of gene structure, order,
and position in the Syrian hamster genome, coupled with comparison to the mouse genome, we have identified
plausible candidates for the genes encoding the classical class I and class II MHC molecules of the research
Syrian hamster. We also discovered that select monoclonal antibodies (mAbs) raised to mouse MHC molecules
cross-react with splenocytes of Syrian hamsters. In Aim 1, we will generate a group of cell lines, each of which
will express a single candidate hamster MHC molecule. These “mono-allelic” cell lines will allow us to
characterize the cross-reactivity of the anti-mouse mAbs in terms of which hamster MHC candidates they are
recognizing, thus enabling the tentative identification of the candidates as genuine MHC molecules. We will verify
that the cell lines can present peptides to stimulate T cells from infected or vaccinated hamsters, using SARS-
CoV-2 as a model system. An important practical advance to arise from this work will be the ability to create
peptide/MHC tetramers to follow T cell responses in hamsters. In Aim 2, we will define binding motifs for the
hamster MHC molecules from the sequences of their natural ligands and create binding matrices to permit the
identification of candidate T cell epitopes for pathogens of interest. This will permit the confirmation of the
hamster candidates as true MHC molecules capable of presenting diverse arrays of peptides. Primary anchor
residues and the most common peptide lengths will also be revealed. The sequences of the eluted peptides will
be used to develop binding matrices that will permit prediction of candidate T cell antigens and epitopes for any
current or emerging pathogen that can be modeled in the Syrian hamster. Our project will achieve the
identification and functional characterization of the class I and class II MHC molecules of the Syrian hamster,
enabling advanced studies of T cell immunity and greatly enhancing its utility as a model for diseases relevant
to human health.

Public health relevance
PROJECT NARRATIVE Syrian hamsters are an excellent model for the study of many conditions that afflict humans, including COVID-19, the disease caused by the SARS-CoV-2 virus. Cells of the immune system called T cells are important in fighting infections by a virus; however, it is hard to study T cells in the hamster because of a lack of knowledge about the animal’s major histocompatibility complex proteins, which direct T cell responses. Our project will fill this gap, with the ultimate goal to reduce the human suffering and death caused by viruses.